Video-based Intervention to Reduce Treatment and OUtcome Disparities in Adults Living with Stroke or Transient Ischemic Attack (VIRTUAL)

Project Summary:
Hypertension is the most important risk factor for ischemic and hemorrhagic stroke, and reduction in blood
pressure (BP) after stroke is associated with reduced risk of stroke recurrence1-4. However, for the majority of
stroke survivors (SS), hypertension remains poorly controlled early after an incident stroke.5-7 In the United
States, Black and Hispanic SS are more likely to have poorly controlled risk factors after stroke compared to
White SS, and Black and Hispanic SS have higher rates of stroke recurrence compared to White SS.5-11 Prior
efforts to reduce racial disparities in BP control among SS have been uniformly unsuccessful.12
Multicomponent care models that include multidisciplinary approaches show promise for improving risk factor
control after stroke.13, 14 Social determinants of health (SDOH) help to explain racial disparities in BP control
and stroke recurrence, therefore multidisciplinary post-stroke care models that target SDOH may be key to
decreasing disparities in BP control.5, 7, 15 Limited access to post-stroke outpatient care contributes to
challenges in developing system-level interventions for post-stroke BP control. Telemedicine and
telemonitoring may be ideal approaches for improving access to care in SS. The COVID-19 pandemic has led
to rapid expansion of telemedicine for post-acute care in stroke survivors; however, its effectiveness is
unproven. Based on preliminary data at our center, we propose a randomized trial testing an integrated
multidisciplinary telehealth intervention, the Video-based Intervention to Reduce Treatment and OUtcome
Disparities in Adults Living with Stroke or Transient Ischemic Attack (VIRTUAL), in SS recently discharged
home after inpatient hospitalization for ischemic stroke, hemorrhagic stroke, or transient ischemic attack. The
intervention will include post-discharge telehealth visits by a multidisciplinary team, social risk assessments to
facilitate social risk-targeted and social risk-informed care, and home BP telemonitoring and management. The
care team includes neurology providers (physician and nurse practitioner), a pharmacist, and a social worker.
Standard care will include follow-up with a neurologist and primary care provider and pharmacist-assisted BP
adjustment. We aim to assess 1) the impact of the intervention on BP control 6 months following stroke
assessed with ambulatory BP monitoring; 2) the impact of the intervention on recurrent vascular events 1 year
after stroke; 3) the impact of the intervention on health services access and utilization following stroke; 4)
moderating effects of race / ethnicity on the impact of the intervention on BP control, vascular events, and
health services utilization; 5) the relationship between additional measured SDOH and primary and secondary
outcomes.

Public health relevance
Project Narrative The purpose of this project is to perform a randomized comparative effectiveness trial to assess the impact of a multidisciplinary telehealth intervention aimed at improving outpatient blood pressure control and decreasing disparities in blood pressure control in a racially and ethnically diverse cohort of ischemic and hemorrhagic stroke survivors by incorporating a social determinants of health approach into the care model. Hospitalized stroke survivors will be enrolled in the study prior to hospital discharge. Post-stroke care for stroke survivors enrolled in the intervention will include remote BP monitoring, video visits, and an integrated approach to care by a multidisciplinary team that includes a social worker, pharmacist, and stroke clinical provider.